MODULATION OF CYTOKINE PRODUCTION IN LPS MEDIATED LUNG INJURY

This project seeks to define the events that are responsible for the lipopolysaccharide (LPS) induced lung injury that leads to ARDS in association with gram-negative sepsis. We have elected 1) to focus on gram-negative infection because it is a common antecedent of ARDS, and 2) to focus on lipopolysaccharide (LPS), because it is a well-established component of gram-negative bacteria and plays an important role in the induction of the host response. Aim 1 seeks to define the role of tyrosine kinases in transduction of the signal for production by mononuclear phagocytes of pro-inflammatory cytokines in response to LPS. It is hypothesized that one or more members of the arc-family of tyrosine kinases are important in this process. The identification of kinases that do play an important role in this process will be addressed by a combined biochemical and molecular biological approach. It is also hypothesized that one or more of the src-family kinases participate in membrane proximal events in LPS-induced signal transduction. This will be addressed by determining which of the events required for expression and secretion of tumor necrosis factor-alpha (TNF-alpha) and IL-1beta are blocked by inhibition of tyrosine kinase function or expression. The third aspect of Aim 1 will apply these observations by testing the effect of prototype tyrosine kinase inhibitors on the production of pro- inflammatory cytokines lung vascular injury and lethality in the rabbit model of LPS induced ARDS described in Aim 4 of Project 6. Aim 2 seeks to determine the role of interferon-gamma (IFN-gamma) in LPS induced pulmonary vascular injury and lethality using, as a model, transgenic mice. The first aspect of this aim will address the hypothesis that IFN- gamma contributes to ARDS-like lung injury and lethality induced by LPS. This will be addressed in transgenic mice in which expression of the IFN- gamma gene has been perturbed, so as to increase or restrict its expression in response to LPS. Although IFN-gamma is produced both by T cells and by NK cells, data from other systems suggests that the NK cell may be the major source of IFN-gamma in response to acute challenge with bacteria or their products. Thus, the second aspect of this aim addresses the hypothesis that NK cells, rather than T cells are primarily responsible for the production of IFN-gamma in response to LPS. This will be addressed by creating transgenic mice in which expression of IFN- gamma is selectively permuted in T cells or in NK cells. The response to LPS of these mice will be compared to mice with normal or non- selectively perturbed expression of IFN-gamma. These studies will further our understanding of the role of cytokines and the pathways leading to their production in ARDS related to gram-negative infection. The ultimate goal of this project and of the SCOR application in general is to provide insights that will lead to novel therapeutic approaches to the ARDS.